Administrative Core

SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core of the Center on Causal Data Science for Child and Adolescent Maltreatment
Prevention (CHAMP Center) will oversee coordination and integration of the two research projects and two
other cores needed to discover, translate, and disseminate knowledge critically needed to prevent
maltreatment of children. To do this, the Administrative Core will manage day-to-day operations, involving
procurement, finances, personnel, planning, and budgeting; build effective processes to facilitate
communication and collaboration; monitor progress towards specific milestones; engage national leaders in the
academic and social services communities to draw on their expertise in maltreatment, traumatic stress, and
data science; develop new collaborations; and troubleshoot problems. By ensuring the smooth and integrated
operation of the fiscal, regulatory, and intellectual needs of the CHAMP Center, the Administrative Core will
play an indispensable role in Center’s overall mission to discover, implement, and scale new approaches to
prevent maltreatment exposure and mitigate maltreatment-related outcomes.